Building Resilient Food Safety Infrastructure in West Virginia: Enhancing Laboratory Capabilities and Capacity under the Laboratory Flexible Funding Model

Building Resilient Food Safety Infrastructure in West Virginia: Enhancing Laboratory Capabilities and
Capacity under the Laboratory Flexible Funding Model
RFA-FD-25-007
Overall Abstract
Food surveillance testing plays a crucial role in safeguarding consumers and the nation's food supply. To
effectively identify and remove contaminated food from the supply chain, agricultural agencies must
possess the capability to rapidly and accurately detect a wide range of pathogens. The proposed project
aims to enhance West Virginia's food testing capabilities and capacity, thereby mitigating risks and
significantly reducing the likelihood of contaminated foods reaching consumers
The West Virginia Department of Agriculture (WVDA) is committed to enhancing the capability and
capacity of the state’s human and animal food testing laboratories to support a comprehensive integrated
food safety system. This initiative includes expanding ISO-accredited sample collection and testing
services in microbiology and chemistry, ensuring compliance with FDA standards. Additionally, the
WVDA will undertake specialized projects to further develop and expand related testing capabilities. A key
focus will also be on strengthening collaboration and improving surveillance activities with the FDA and
other laboratory partners, fostering a more cohesive and efficient network.
The West Virginia Department of Agriculture serves as the primary regulatory agency for human and
animal food product testing and is also the primary regulatory agency for the testing of manufactured
foods (MFRPS) and animal food (AFRPS) in WV.
The laboratories maintain accreditation for eighteen methods under ISO 17025 standards, demonstrating
their commitment to quality and precision. As an active member of the Food Emergency Response
Network (FERN) since 2005, the agency has contributed significantly to food safety by completing method
development, single and multi-laboratory method validations, and conducting surveillance activities.
Additionally, the WVDA plays a vital role in food defense, actively performing microbiological and
chemical analyses of foods to ensure safety and preparedness.
The WVDA has consistently demonstrated its commitment to achieving the objectives of this cooperative
agreement through its robust infrastructure, skilled personnel, ISO 17025 accreditation, innovative
research projects, method development initiatives, and ongoing surveillance efforts. This project will
further enhance the WVDA's human and animal food surveillance capabilities and capacity, while
reinforcing an integrated food safety system through strengthened collaboration with the FDA.

Public health relevance
Building Resilient Food Safety Infrastructure in West Virginia: Enhancing Laboratory Capabilities and Capacity under the Laboratory Flexible Funding Model RFA-FD-25-007 Overall Narrative Enhanced surveillance sample analysis plays an imperative role in preventing illnesses caused by contaminated human and animal food. The proposed project aims to significantly improve the food testing capabilities and capacity in West Virginia. By strengthening these testing efforts, the initiative will directly reduce the likelihood of contaminated foods reaching consumers, safeguarding public health and ensuring food safety.